Identifying novel modes of oncogenic signaling in multiple myeloma

The Young lab's research program is organized around two primary aims to address treatment resistance in multiple myeloma (MM). The first focus is on oncogenic RAS signaling, a key driver in up to 70% of relapsed/refractory cases. Our work has revealed that mutant RAS in MM uniquely co-opts endolysosomal machinery to activate the mTORC1 growth pathway. More recently, we identified novel regulators of RAS protein stability-the phosphatase PP1C, which promotes its degradation, and PAK kinases, which protect it-offering new avenues for therapeutic intervention. Building on these discoveries, we are assessing novel pan-RAS inhibitors, searching for synergistic drug combinations, and exploring the targeting of lysosome function as an alternative strategy to disrupt this pathogenic network. A second major effort employs a broad, unbiased proteogenomic strategy to uncover novel dependencies. Recognizing that genomic data alone has not yielded sufficient therapies, we are building a comprehensive functional map of gene essentialities using CRISPR screening across an extensive panel of MM cell lines, including unique models of advanced, treatment-refractory disease. A key success of this approach is the identification of the SWI/SNF chromatin remodeling complex as a critical vulnerability. We demonstrated that SWI/SNF activity is required to sustain the master transcription factor IRF4, and that its inhibition triggers a collapse of oncogenic networks driven by both IRF4 and MYC. This finding presents a powerful strategy for treating aggressive, IMiD-resistant MM and serves as the foundation for our ongoing proteogenomic screens to identify new vulnerabilities within the MYC oncogene network.